Cellular Mechanisms of Antidepressant Action.

Depression and anxiety disorders are debilitating illnesses that affect more than 350 million people wordwide.
The most common treatments for these disorders are SSRIs (selective serotonin reuptake inhibitors) which
block the serotonin transporter and thereby increase serotonin levels in many brain regions. However, about
50% of patients who take SSRIs do not fully respond and among those who respond a significant fraction
experiences various side effects such as sexual dysfunction. In addition, SSRIs have a delayed onset of
therapeutic efficacy of several weeks. There is therefore a considerable need for better and faster acting
antidepressants. One way to develop novel antidepressants is to understand how SSRIs work and why they
take so long to be effective and then to target directly the underlying mechanisms. One of the dominant
hypothesis in this field is that downstream of the increase in serotonin elicited by SSRIs there are a number of
growth related changes such as an increase in hippocampal neurogenesis and a rewiring of limbic circuits that
are responsible for the delayed onset of efficacy of SSRIs.
We have discovered several lines of evidence pointing to the ventral hippocampus and specifically the ventral
dentate gyrus (DG) as being critical for many of the antidepressant and anxiolytic-like effects of chronic SSRIs
in animal models. In the current application, we propose to build on these results to understand how a chronic
exposure to SSRIs modifies the activity of the ventral DG and consequently of the ventral hippocampus and
the limbic structures it influences, to generate an antidepressant response. To achieve this goal, we propose to
assess the activity of the ventral hippocampus in response to chronic SSRIs with calcium imaging and
miniscopes in freely moving mice. Our overarching hypothesis is that the concerted action of SSRIs on young
and mature granule cells of the ventral DG results in a decrease in the activity of the DG and consequently a
decrease in the activity of “anxiety cells” located in the ventral portion of CA1 and projecting to the limbic
system, ultimately resulting in antidepressant and anxiolytic-like effects.
These studies will therefore enable us to identify changes in the function of the ventral hippocampus that are
produced by a chronic treatment with SSRIs and that are critical for the antidepressant response in animal
models. Such knowledge will in turn inform novel therapeutic approaches aimed at targeting directly specific
cells in the ventral hippocampus in order to develop faster and more efficacious antidepressants.
!

Public health relevance
SSRIs are currently the first line treatment for depression and anxiety disorders but they work slowly and in only about 50% of patients. We propose here to study the activity of select populations of brain cells that are critical for their action and that are located in a brain region called the ventral hippocampus. Our hope is to identify novel targets that may lead to better antidepressant therapies.